Diabetes Endothelial Keratoplasty Study (DEKS): Impact of Diabetes and Other Predictors on Corneal Transplant Endothelial Cell Loss and Success

Project Summary
The proposed Diabetes Endothelial Keratoplasty Study (DEKS) Renewal will follow up from the initial
findings of the DEKS, driving evidence-based decisions regarding use of corneal tissue from donors
with diabetes for Descemet membrane endothelial keratoplasty (DMEK), the leading form of endothelial
keratoplasty in the US. There remains the need to definitively resolve the discrepant findings regarding
the use of diabetic donor tissue to guide the corneal transplant community. While we hypothesize that
overall non-diabetic corneas are superior, it is unlikely that all donors with diabetes are inferior. Rather,
based on preclinical and DMEK eye bank stripping data, we presume that the extremes of diabetes
severity in donors drive the adverse effects on DSAEK outcomes that our group noted in the Cornea
Preservation Time Study (CPTS) where diabetes in donors and recipients was not collected
systematically. In the current DEKS, we seek to determine graft success varies between donor
subgroups predefined by presence or absence of diabetes as well as various diabetes severity scales
after 1 year of follow-up which we expect will be welcomed findings by eye banks and corneal surgeons
guiding them to avoid inefficient distribution of inferior tissue for DMEK. However, the current DEKS,
with follow-up limited to 1 year, does not address long term endothelial cell loss (ECL) and
accompanying graft failure of diabetic vs non-diabetic donors as well as the recipient diabetes effect.
Nor does it examine long term effects of diabetes severity and other predictors (genetic) on ECL and
graft failure. The renewal of the DEKS would address this by a powered analysis of long-term ECL out
to 5 years as a marker for graft survival in the first specific aim while exploring impact on graft failures
in the second specific aim. The third specific aim in the renewal of DEKS will be continuation of the
third specific aim in DEKS, exploring the relationship of severity of diabetes in the donor (as measured
by eye bank-determined diabetes risk categorization scores, post-mortem HbA1c, and skin AGEs and
oxidation markers), and in the recipient (as measured by diabetes risk categorization scores, and
HbA1c). In addition, in the most novel aspect of this renewal, we will explore donor and recipient
genetics (mutations in TCF4, other Fuchs dystrophy genes, and diabetes polygenic risk scores) on ECL
and graft failure 5 years following DMEK. These long-term insights on the diabetic donor and associated
graft outcomes as well as recipient diabetic status and Fuchs genetics will provide further guidance to
the eye banking and corneal transplant surgeon community on the use of an increasing number of
diabetics in the corneal donor pool and increasing number of diabetics in recipients also affected by
Fuchs Dystrophy.

Public health relevance
Project Narrative Diabetes Endothelial Keratoplasty Study (DEKS): Impact of Diabetes and Other Predictors on Corneal Transplant Endothelial Cell Loss and Success As individuals with diabetes comprise an increasing proportion of the donor cornea pool as well as the recipients of the donor tissue, questions continue to arise regarding the suitability of tissue from donors with diabetes for corneal transplantation, a major health concern considering 50,925 tissues were distributed by United States eye banks and used for corneal transplants by United States surgeons in 2023. The DEKS Renewal will conduct long term follow-up for 5 years on patients enrolled in a large, prospective, multicenter, masked clinical trial assigning corneas from donors with or without well characterized diabetes status to patients undergoing corneal transplantation, also characterized by diabetes status. The study will examine long term endothelial cell loss and graft success after surgery, definitively determine the impact of donor and recipient diabetes on these outcomes, and thus help guide the eye banking and surgical community as to the safety and effectiveness of transplanting donor corneas from individuals with diabetes.